Oxidative Response Networks in Chagasic Cardiomyopathy

SUMMARY
Chagas disease (CD) caused by Trypanosoma cruzi (Tc) represents third greatest tropical disease burden
as it affects >7 million people and causes >17,000 deaths and ~$8.0 billion in health care expenses and lost
productivity every year. Ca2+-mitochondria disorders and oxidative/inflammatory stress are hallmarks of
chagasic cardiomyopathy and heart failure.
Our preliminary studies have identified a new dimension of CD pathogenesis. We found that alternative
splicing (AS) of Ca2+ cycling genes specifically Atp2b1 (PMCA1) and Atp2a3 (SERC3) that signal nuclear Ca2+
and gene transcription, and alternative polyadenylation (APA) of mitochondria function related mRNAs (mf-
mRNAs) were increased in CD. Rbfox2 (encodes an RNA binding protein of FOX family) switch from wild-type
to exon1/2-skipping isoform was linked to AS events in CD, Rbfox2 knockdown led to similar AS pattern and
delayed Ca2+ transients as were noted in infected cardiomyocytes, while PARP1 (polyADP-ribose polymerase)
deletion improved the Atp2b1/Atp2a3 splicing pattern. Further, we identified that RBFOX2 binds to polyA tail
nascent mRNAs, polyADP-ribosylation of CPSF73 and PAP that have essential function in polyA site selection
and polyA synthesis was increased in CD, and Parp1-/- mice exhibited improved myocardial mf-mRNAs’ levels,
and mitochondrial and LV function that were compromised in Tc-infected wild-type mice.
Building on these and other preliminary data, we hypothesize that PARP1/RBFOX2 dictated RNA
processing events create an environment for nCa2+-mitochondrial disequilibrium and resultant
oxidative/inflammatory stress and LV dysfunction in CD. Using Parp1+/+, Parp1-/-, and Parp1CKO (newly
generated by us) mice that exhibit none, whole body, and cardiomyocyte-specific PARP1 deletion,
respectively, and advanced molecular tools, proposed studies will identify the mechanisms by which
maturation, stability, and cellular function of mRNAs are dysregulated in CD. Studies in aim 1 will examine the
time-course of Rbfox2 isoform switch, regulatory mechanisms involved in AS in CD and determine if enhancing
RBFOX2/PARP1 balance can restore nCa2+/transcription equilibrium, and cardiomyocytes function in Tc
infection. Studies in aim 2 will examine the novel mechanisms by which PARP1 disturbs site-specific function
of CPSF73/PAP/RBFOX2 to influence the polyadenylation and stability of mf-mRNAs in CD.
The proposed work is highly innovative as it will demonstrate for the first time the mechanisms by which
pre-mRNAs processing and maturation are disturbed in infectious cardiomyopathies. The findings of global
AS/APA networks in healthy and diseased heart will present promising and exciting fields for future research.
The impact of the proposed studies is very high, as testing of PARP1 inhibitors, RBFOX2 enhancers and
antisense oligonucleotides (ASOs) will offer broad-range new therapeutics targeting splicing and
polyadenylation functions with relevance to preserving the nCa2+-mitochondrial homeostasis in diseased heart.

Public health relevance
PROJECT NARRATIVE We will identify at the molecular level how RBFOX2 and PARP1 regulate Ca2+-mitochondrial equilibrium in healthy and diseased heart. Our findings will present promising and exciting opportunities for the development of new therapeutics targeting splicing and polyadenylation functions with relevance to correcting gene transcription and mitochondrial metabolism in heart disease of CD (and other) etiologies.